New radical-based strategies for reaction discovery

Project Summary
The proposed research will uncover new radical-based methodologies that facilitate the synthesis of
complex bioactive compounds. Organic radicals are highly reactive species with unique
chemoselectivities that complement canonical two-electron chemistry. Recently, the emergence of new
reaction strategies that leverage single-electron redox events and harness radical intermediates for the
selective functionalization of organic molecules has provided chemists with useful tools for solving
contemporary synthetic problems. However, the highly reactive nature of many organic radicals has
made it difficult to impart catalyst-control over the regio- and stereoselectivity of these fleeting
intermediates, especially when complex reaction systems are concerned. In the past funding period, we
developed new catalytic strategies that leverage the unique redox features of low-valent Ti complexes to
achieve redox-neutral and net-reductive transformations, and through catalyst innovation, we
demonstrated that free radical-mediated reactions can be made highly enantioselective. These promising
results prompted us to continue to invent novel catalytic and reaction strategies that can effectively
harness radical intermediates and provide powerful tools for solving a range of longstanding synthetic
problems. In the new funding cycle, we will build on our previous success while moving our research into
important new areas of inquiry. In the proposed work, we aim to advance new approaches that employ
radical-based catalysts or reagents to address prominent challenges in organic synthesis. The
transformations targeted in each project area are either currently unknown or significantly limited in
reaction scope or selectivity. Some of the specific reactions that we aim to develop are: site-selective
oxidation of alcohols, enantioselective oxidation of amides and ethers, oxidative synthesis of stereogenic-
at-phosphorous(V) compounds, site-selective amination, halogenation, and desaturation of alkanes, and
deconstructive functionalization of alcohols. In-depth studies using canonical physical organic and
electroanalytical techniques will provide insights into the reaction mechanisms that will be used to guide
optimization. Ultimately, the realization of these proposed transformations will represent a significant
advance for the field of organic synthesis and support innovation in the synthesis of biomedically
important molecules.

Public health relevance
Project Narrative To assemble complex molecules rapidly, efficiently, and with predictable outcomes is among the most significant challenges in the discovery of new medicinal agents. This proposal addresses several major technological gaps in the field of organic synthesis, and its successful completion will speed the preparation of novel medicinal lead structures.